MAIT cells in lupus skin disease and photosensitivity

Project Summary / Abstract
Systemic lupus erythematosus (SLE, lupus) is a multi-organ autoimmune disease with 5-10%
mortality in 10 years. Skin is severely affected by this disease and sensitivity to ultraviolet (UV)
sunlight rays affects up to 80% of patients. The immunologic mechanisms involved in cutaneous
lupus (CLE) remain poorly understood. In particular, the role of different types of T cells, highly
prevalent lymphocytes in CLE skin, is unknown. The overall objectives in this proposal are: (i) to
profile and determine the function of MAIT cells in CLE in relation to the skin microbiome and (ii)
to define the role of MAIT cells in lupus skin disease and photosensitive responses in vivo. The
central hypothesis is that activation of MAIT cells, influenced by preferential expansion of
riboflavin-producing bacteria, mediates skin pathogenesis in CLE. The rationale for this project
stems from the gap in the knowledge of how the altered microbiome in lupus skin impacts immune
activation, and specifically MAIT cells, and leads to tissue damage. The central hypothesis will be
tested by pursuing two specific aims: 1 Define how skin microbiome shapes MAIT cell function in
CLE patients and 2) Establish how lupus-specific interactions between skin microbiota and MAIT
cells mediate cutaneous lupus in vivo. Under the first aim, MAIT cells from lupus skin (lesional
and unaffected) will be evaluated for quantity, heterogeneity, transcriptomic signatures, and TCR
usage (relative to healthy skin) and these findings analyzed in relation to the abundance of
microbial communities and riboflavin gene expression. For the second aim, the role of MAIT cells
in the development of lupus skin disease will be evaluated in Mrl-lpr mice deficient in MAIT cells
(Mrl.lprMR1-/-). This new murine strain will be used to investigate how dermal association with
riboflavin or Staphylococcus bacteria influences MAIT cell function in spontaneous and UV light-
accelerated CLE in vivo. The research proposed in this application is innovative because it will
generate a novel mechanism of lupus skin disease and interrogate a T cell population reported to
have inflammatory properties in other skin disease but has not yet been studied in CLE. The
proposed research is significant because it is expected to provide a strong scientific rationale to
address the imbalance in lupus skin microbiome and/or modulate MAIT cells for therapeutic
purposes in lupus skin disease.

Public health relevance
Project Narrative Understanding how skin commensal bacteria shape pathogenic MAIT cell responses is essential to elucidating the pathogenic mechanisms in lupus skin, characterized by disbyosis and notable T cell presence. This application directly addresses the NIH Stephen Katz funding opportunity as it proposes an innovative project that represents a change in research direction, while also supporting the programmatic objectives of the NIAMS Skin Biology and Diseases program. In addition to advancing the understanding of the immune cell – microbiome interactions in lupus skin, these studies will define targetable pathways to prevent lupus skin disease, thus addressing the NIH’s mission to enhance health and reduce the burden of illness.